Etiological Role of Parasitic Exposure and Familial Susceptibility in Nodding Syndrome-Related Epilepsies

Project Summary
The K01 application for Dr. Rajarshi Mazumder, a board-certified epileptologist at University of California, Los
Angeles, will allow him to establish as an independent investigator in global health and epilepsy research. The
K01 will provide Dr. Mazumder support and protect time to achieve the following career development goals: 1)
gain expertise in molecular epidemiology-- training in design and conduct of research using genetic data and
model the effects of genes and their interactions with environmental factors; 2) Advanced statistical training for
population health; 3) Lead research in a resource-constrained setting and training in the responsible conduct of
research in global health; 4) Grant writing. To accomplish his career goals, Dr. Mazumder has assembled a
team of mentors with complimentary expertise in Uganda and the US. More than 80% of people with epilepsy
live in low-to middle-income countries, where despite the high incidences, many commonly occurring
epilepsies remain understudied and poorly characterized. Nodding syndrome and related epilepsies are such a
constellation of epileptic brain disorder that occurs in several sub-Saharan African countries. Although the
etiology of this disease is unknown, several studies have found a consistent association with the parasite,
Onchocerca volvulus (OV). As the OV parasite is not neuroinvasive, autoimmunity to Hu-Leiomodin-1, a
muscle-associated protein, due to molecular mimicry with OV antigens is thought to play a role in the
pathogenesis. Studies have also found that variations in immune responses due to HLA polymorphism might
also contribute to the etiology. However, the role of host genetics and its relationship to exposure to OV in the
manifestation of epilepsy is yet to be systematically investigated. The central hypothesis of this proposal is that
families with NS share common electroclinical features forming a distinct familial epilepsy syndrome and this
electroclinical phenotype is conferred by O. volvulus-associated hu-Leiomodin-1 autoimmunity in genetically
susceptible individuals. We will pursue the following aims: 1) Characterize the epilepsy sub-phenotypes that
aggregate within the NS-affected families; 2) Investigate the role of genetic polymorphism in the human host
underlying the pathogenesis of NS-and related epilepsies; 3) Evaluate the relationship between exposure to
OV-associated Hu-leiomodin-1 antibody and host susceptibility that jointly confers risk for NS-and related
epilepsies. This study has a high global health significance, as it aims to mechanistically understand how a
parasitic disease modifies the risk of epilepsy in susceptible individuals. There is an urgent need of this
evaluation to further mitigate the risk of a neglected tropical disease. The proposal will prepare Dr. Mazumder
as an independent researcher and provide the foundation for future R01 funded studies to prevent acquired
epilepsies by early identification of susceptible individuals.

Public health relevance
Project Narrative Despite the high burden of epilepsies in sub-Saharan Africa, many commonly occurring epilepsies remain understudied and poorly characterized. This proposal focuses on improving our understanding of the role of host genetics and its relationship to exposure to Onchocerca volvulus, a commonly occurring parasite, in the manifestation of epilepsy. Advances from these studies will provide mechanistic insights into epileptogenesis of acquired epilepsies and new targets for developing preventive measures.